The Progranulin C-Terminal Domain and AAV-Progranulin Gene Therapy for Frontotemporal Dementia

Project Summary
This application is for F30 support of Shreya Kashyap during her MD/PhD training. The scientific focus of this
proposal is to determine the role of the progranulin C-terminal domain (CTD) on AAV-derived progranulin levels
in vivo and the effectiveness of AAV-Progranulin gene therapy. Heterozygous loss of function mutations in the
progranulin gene (GRN) are one cause of frontotemporal dementia (FTD), a devastating neurodegenerative
disease characterized by social behavior and language deficits. Work from the lab of Dr. Erik Roberson, sponsor
of the PI, has established the therapeutic potential of AAV-Progranulin gene therapy in progranulin-insufficient
mouse models of FTD. The vector used for these experiments has a tag fused to the CTD that precludes
progranulin's interaction with its canonical trafficking receptor, sortilin. These experiments show that the
lysosomal localization and efficacy of AAV-Progranulin is independent of sortilin. However, the functional
consequences of an exposed progranulin CTD, which allows for progranulin-sortilin binding, are still unknown.
Notably, sortilin mediates the uptake and degradation of progranulin and sortilin ablation or inhibition boosts both
brain and CSF progranulin levels in wild type and progranulin-insufficient mouse models. My preliminary
experiments indicate that blocking the progranulin C-terminal domain boosts parenchymal levels of AAV-derived
progranulin, and improves efficacy of AAV-Progranulin in rescuing lysosomal pathology and neuroinflammation.
The clinical translation of AAV-Progranulin vectors with tags fused to the progranulin CTD is unlikely. Thereby,
it is important to determine CTD sequence modifications that improve dosage and levels of AAV-Progranulin.
Immune mediated clearance of AAV particles and AAV-transduced cells reduce the effectiveness of AAV-
based gene therapies. Progranulin-deficient mice mount an immune response to AAV-murine progranulin, and
it is unclear if FTD-GRN patients (who have one functioning progranulin allele) will mount an immune response
to AAV-human progranulin. However, as evidenced by recent clinical testing of AAV-glial derived neurotrophic
growth factor (AAV-GDNF) and AAV-amino acid decarboxylase (AAV-AADC) in patients with Parkinson's
disease, patients can mount immune responses even to AAV-derived proteins with non-foreign epitopes. Thus,
it is important to identify sequence modifications that reduce immune cell uptake of secreted AAV-derived
progranulin. Because sortilin is expressed by various antigen presenting cells in the brain, blocking the
progranulin-sortilin interaction has the potential to decrease the immunogenicity of AAV-Progranulin vectors.
The proposed training plan for Shreya Kashyap is sponsored by her project mentor, Dr. Erik Roberson. The
overall goal of the training plan is to provide the PI with a solid foundation for a successful career as a physician
scientist. A project based both in translational approaches, while focused on a disease-oriented pathogenesis,
is the ideal training environment for any aspiring physician scientist.

Public health relevance
Project Narrative Heterozygous loss of function mutations in the progranulin gene are one cause of frontotemporal dementia (FTD). Sequence modifications at the progranulin C-terminal domain may improve the therapeutic potential of AAV-Progranulin gene therapy by blocking progranulin's interaction with sortilin, a receptor known to regulate progranulin uptake and degradation. Completion of the experiments outlined in this proposal will directly inform the design of AAV-Progranulin gene therapy for patients with frontotemporal dementia.